Reproductive and Child Health Trajectories in Successive Novel Infectious Disease Crises

PROJECT SUMMARY/ ABSTRACT
The objective of this proposed research is to provide one of the first in-depth, mixed-method analysis of
women's reproductive trajectories in the context of successive novel infectious disease crises – Zika in 2015-
17 and Covid-19 since 2020 – in a country hard-hit by both these epidemics/pandemics. These analyses will
center on how contextual and individual-level experiences with these shocks have influenced women's
reproductive lives both in the short-term and long-term. Understanding women's reproductive responses to
successive novel infectious disease crises is key to developing a nuanced understanding of how the impact of
these shocks extend beyond mortality to fertility and reproductive wellbeing. With scientists predicting an “era
of pandemics” characterized by increased risk of novel infectious disease crises, it is pertinent to consider how
the successive nature of such population health shocks have lasting, interconnected implications for the course
of women's reproductive lives. This is especially important in the context of a developing country where vast
inequalities in economic security, healthcare access, unintended pregnancy, and morbidity and mortality
persist. Currently, little population-based data or research is available on how women's reproductive
trajectories have evolved through different stages of the Covid-19 pandemic anywhere, and in the wake of the
Zika epidemic. To address this, the proposed study will expand upon an existing three-year longitudinal study
(DZC-1), the first-ever panel study on women's reproductive lives in Brazil of any kind, for an additional three
years to generate one of the longest empirical records of reproductive trajectories of a multi-age cohort (ages
18-34 in 2020) of women (DZC-1-2). This data will be collected twice each year for the next three years and
include information on individual and municipality Zika and Covid experiences, reproductive intentions,
behaviors, and outcomes (with questions on monthly contraceptive use history and relationship history), and a
range of potential mediators such as risk perceptions, knowledge about disease transmission, economic
vulnerability, healthcare access, and contraceptive self-efficacy. We will link new waves of data with DZC-1
waves to understand if, and how, the experience of living through successive health shocks produces
immediate, lagged, and compounded effects. We will also merge DZC 1-2 data with municipality and census
tract data (e.g., vaccine availability, Covid-19 case rates and death rates) to address the implications of
contextual Covid-19 conditions on reproductive processes. In addition to creating a 6-year panel, the aims of
this study are to examine how varied individual and contextual Covid-19 experiences across space and time
have influenced women's reproductive lives, including their child's health. We will use panel data methods and
difference-in-difference models for our proposed analyses. We will add nuance to these analyses with in-depth
interviews to understand how women classified as outliers (e.g., unvaccinated (vaccinated) women in low
(high) municipalities) navigated pregnancy during the Covid-19 pandemic.

Public health relevance
PROJECT NARRATIVE The proposed study will expand an existing longitudinal study (DZC-1), the first panel survey of reproductive lives in Brazil of any kind, to lengthen the observation interval of respondents by three years stands to generate one of the longest empirical records for examining the reproductive lives of a multiage (18- 34 in 2020) cohort of women (and their children) in response to highly consequential successive novel infectious disease crises. With established rapport with the community and instituted local survey capacity in an epicenter of Zika and Covid-19, our proposed approach advances critical knowledge on the extent to which Covid-19, and successive generalized epidemics, which have become increasingly common, are consequential to women's reproductive lives, including their young children's health. The findings promise to advance research and theory on successive novel infectious disease shocks by examining individual- and contextual-level effects on women's reproductive lives and trajectories, which can inform policy and outreach efforts to reduce unmet need for contraception and unintended fertility amidst major reproductive health crises.